Epitope-Based CSP Vaccines Optimized to Achieve Long-Term Sterile Immunity

Abstract
Given the very high burden malaria imposes on many developing countries and the continued need for an
effective vaccine, the objective of this proposal is to develop a Plasmodium falciparum (Pf) vaccine by taking
advantage of the knowledge gained in the last few years isolating and characterizing protective human
monoclonal antibodies specific for major coat protein of the parasite, circumsporozoite (CS) protein. The
malaria vaccine candidates currently most advanced in the clinic, RTS,S and R21, target only the major NANP
repeat of the PfCS protein plus T cell epitopes in the C-terminal domain. Current limitations of the RTS,S
vaccine have been the 30-50% efficacy and transient protection. A further potential complication is pre-existing
immunity/tolerance to the HBsAg carrier, which is derived from a human pathogen. To circumvent these
problems we have developed a non-human pathogen-derived carrier platform, specifically the core protein
from the woodchuck hepadnavirus (WHcAg). Modified WHcAg VLPs are used as the vaccine platform for
several reasons: WHc-CS hybrid VLPs elicit extremely high levels of anti-CS protective antibodies; new
protective epitopes can be added simply; and since WHc-CS hybrid VLPs can be made in bacteria, the vaccine
will have a low cost-of-goods. In preliminary studies we developed a WHc-CS hybrid VLP that contains two
neutralizing Pf-CS repeat B cell epitopes and three “universal” malaria-specific T cell domains. This WHc-CS
hybrid VLP (designated VLP-162) is very immunogenic in mice and rabbits and elicits neutralizing anti-CS
repeat antibodies that prevent P. berghei/Pf hybrid sporozoite liver infection in vivo and produces sterile
immunity to blood stage infection in 90-100% of mice. Our approach is to expand the scope and protective
efficacy of VLP-162 by adding B cell epitopes defined by the protective human Mabs CIS43, 313/317, L9 and
5D5, plus expand the CS-specific T cell epitopes delivered by the VLP. The strategy for developing an optimal
next-generation malaria vaccine is divided into 3 aims: Aim 1) build on VLP-162 by incorporation of the newly
defined CS-derived protective B cell epitopes and broadening the number of CS-specific T cell epitopes; Aim
2) optimize immunogenicity by assessing adjuvant formulations in multiple mouse strains; and Aim 3) conduct
in vivo protective efficacy tests in Pf mouse challenge models using PbPf hybrid sporozoites that contain the
entire Pf CS or engineered Pf CS proteins that allow us to measure the contribution of each epitope to
protective efficacy. Combination of these two technologies, the WHcAg platform and the PbPf hybrid
sporozoite challenge models, will allow in vivo protective efficacy to be determined in infectious model
systems.

Public health relevance
Project Narrative Malaria is the world's most important lethal tropical parasitic disease (over 500,000 deaths each year) with an estimated 200 million clinical new illnesses each year. Natural P. falciparum infection requires muiltiple rounds over many years for partial immunity. Further, malaria control efforts are being impeded by the spread of multiple drug resistant malaria and the development of insecticide resistance by the anopheline mosquito vector. Therefore, an effective prophylactic vaccine is urgently needed to prevent further spread of these diseases.